ADMINISTRATION

Administrative services at the UNMC Eppley Cancer Center are defined broadly to include overall management and planning, support of Cancer Center research programs and core facilities, information systems, facilities, and general administrative and financial management. The Cancer Center's Administration is comprised of the following: 1)a Business and Finance Office (finance, research administration and human resources), 2) Outreach and Public Affairs, 3) Information Technology Services and 4) Administrative Support. Administration is integral to the success of the Cancer Center meeting its goals and objectives.